CCR Biophysics Resource Core

The Biophysics Resource (BR) is managed and operated by the Structural Biophysics Laboratory. BR provides expert staff to assist users in the design of experiments and operation of advanced biophysical chemistry technologies such as circular dichroism spectroscopy, LC/MS and LC/MS/MS spectrometry(including high-resolution option), steady-state fluorescence spectroscopy, isothermal titration calorimetry, differential scanning calorimetry, dynamic and static light scattering, microscale thermophoresis for characterization of biomacromolecules and/or their complexes. The BR provides much more than simple instrument availability by training in the use of instruments, maintenance and upgrades of instrumentation, and consultation/collaboration on experimental design and sophisticated analysis of biophysical experiments. The BR assists researchers from other Institutes on a time-available basis.The BR is the only place at CCR providing access to such technologies as titration and scanning calorimetry, circular dichroism, microscale thermophoresis. Majority of BR technologies, even mass-spectroscopy, operate in walk-up mode and experiments are run by users after necessary training. It allows minimization of the time interval for such complex technologies as LC-MS and high-resolution LC-MS-MS between project initialization and final result from days and hours down to minutes, if necessary.